Fostering Institutional Resources for Science Transformation: The FLORIDA-FIRST Health-science Brigade

PROJECT SUMMARY
The goal of The FLORIDA-FIRST BRIGADE is to test a cohort model of hiring, sponsorship, mentoring,
and support for professional development, and the proposed administrative core is designed to seamlessly
manage this effort. Research suggests that minority faculty development programs alone are not
consistently associated with changes in URM representation, recruitment or promotion. Thus, faculty
development is a necessary but not sufficient condition. Studies have identified two primary administrative
barriers to increasing URM faculty representation in biomedical sciences: (1) the need for coordinated
programmatic efforts and resources necessary to address recruitment, retention, and promotion and (2) the
need for a senior leader champion.
Our Administrative Core is designed to address these gaps. The Administrative Core will provide
centralized coordination of fiscal, communications, and organizational management of The FLORIDA-FIRST
BRIDAGE Brigade to maximize efficiency and effectiveness of key innovations. First, we are restructuring our
recruitment procedures to ensure adequate marketing resources and best practices to reduce bias. Second,
we will recruit URM faculty into a center in the Equity Research Corner to ensure unified best practices for
mentoring, sponsorship, administrative support, and promotion procedures. This will create unprecedented
coordinated programmatic efforts. Third, our overall governance structure includes multiple senior lead
champions from different domains, including center directors, Provost Office, Office of Vice President for
Research, and the faculty union (see Figure 4 in the Overall Core). Fourth, we will leverage the translational
research and faculty infrastructure of the UF-FSU’s CTSA with the following mission, “Translational science at
Florida State University engages communities in developing and testing biobehavioral interventions across the
translational spectrum to address sociocultural determinants of health.” Thus, to address administrative
barriers to increasing URM faculty, we propose one overarching aim:
Thus, to address administrative barriers to increasing URM faculty, we propose one overarching aim: Aim.
To institute a nimble administrative structure to harmonize with the existing institutional practices to
successfully implement The FLORIDA-FIRST BRIDAGE.